Measuring and modeling the dynamics of patterning in human stem cells

Abstract
The long-term goal of this project is to understand how cells in complex human tissues sense, process and
respond to signal during normal human development and developmental diseases.
A fundamental question in developmental biology is to understand how tissues are patterned in a developing
animal. This Application will address the question in the context of the patterning of the human pluripotent
cells into mesoderm and endoderm. The first question that will be investigated is how cells sense signal,
followed by a closer look at how the internal gene regulatory network processes this signal to launch a
transcriptional response as the cell chooses its fate.
The first aim of this proposal uses a combination of novel microfluidics to control gradients of signals, genome
modification techniques to fluorescently tag key transcription factors to study their dynamics using
epifluorescence, and image processing and mathematical tools to analyze the data. It further follows up on
the applicant’s recent discovery that key receptors that sense signals are basally localized. This study
demonstrates how the (in)ability of the cell to sense active apical signal due its receptors being localized
basally affect patterning. This is the first study the applicants are aware of to attempt to quantitatively
understand how human stem cells are patterned.
The second aim focuses on understanding how the state of the gene regulatory network within the cell
affects the response to TGF-beta signal during germ layer differentiation in human and mouse. Indeed, cells
even twelve hours apart in development obtained from the same region of the embryo show digitally distinct
responses to the same signal. Single cell gene expression data obtained during the course of development is
used to build a predictive mathematical model of the intracellular gene regulatory network. Building such
predictive mathematical models has been very challenging in the past. Using these models, the goal of this
aim is to uncover whether cells can respond to the same morphogenetic signal in distinct ways depending on
the state of a core gene regulatory circuit. The predictions are checked experimentally in the context of early
human and mouse development using imaging and molecular techniques to perturb gene expression.
The discoveries made by the proposal will lead to a better understanding of how multipotent human cells
respond to signal both during development and in cancer. Furthermore, the ability to build predictive models
of the underlying gene regulatory network opens avenues to understand the mechanisms underlying disease
states in the future.

Public health relevance
Narrative The project seeks to gain a quantitative understanding of how cells perceive and respond to signals during human development. To do so, human embryonic stem cells will be studied using a combination of microscopy, single cell sequencing, statistical inference, mathematical modeling and molecular biology. In the longer term, a quantitative understanding of how the different cell types emerge in the early embryo will help uncover what goes wrong in developmental diseases and cancer.